Serum protein markers along the Alzheimer's disease trajectory in the population-based longitudinal AGES Reykjavik study and their offsprings

Abstract: The incidence of Late Onset Alzheimer's Disease (LOAD) is rising as the world's population ages,
making effective interventions for slowing or halting the disease progression one of the fastest growing unmet
medical needs. With promising medications on the horizon, minimally invasive biomarkers such as plasma
phosphorylated Tau (pTau)-217 can detect a prodromal stage prior to clinically presenting dementia which may
aid in the implementation of LOAD precision medicine. However, not everyone with early amyloid pathology will
progress to develop symptomatic LOAD nor at the same rate. New approaches are needed to identify additional
molecular markers that can inform on the prodromal progression towards LOAD and shed light on its complex
etiology. The proposed study will leverage unique datasets such as the deep circulating proteome (~10,500
proteins) including different proteoforms, rich genotype data and gene regulatory protein networks, all linked to
Aβ and pTau-217 plasma levels, changes in brain volumes and cognitive functioning, and new-onset LOAD from
the prospective population-based cohort AGES Reykjavik study (n = 5,377 at baseline, including 3,215 with
follow-up measurements). Furthermore, by including an offspring cohort of AGES-RS from LOAD parents, the
proposed study will span two generations. The findings will be investigated in the context of APOE-ε4 carrier
status, to follow-up on the apparent dependence or independence of circulating proteins from the high-risk
genotype for links to incident LOAD. Four specific aims are proposed: In Aim 1, the temporal changes in the
circulating proteome along the LOAD-related trajectory will be identified. In Aim 2, a high-throughput Seer
Proteograph mass spectrometry approach will be deployed to orthogonally examine previously established
serum protein relationships with incident LOAD as well as identify novel proteoform links to LOAD. In Aim 3, a
dense genotype imputation and recently acquired whole-genome sequencing data will be used to determine the
mechanisms underlying APOE-ε4 and LOAD related proteome shifts. The results of Aims 1-3 will offer Aim 4
with a panel of unique and robust protein biomarker candidates for further validation in detecting early signs of
cognitive decline, as assessed in a younger population enriched for offspring of LOAD parents. The proposed
project is significant for many reasons including for instance: i) the depth of the genotype, proteome, and clinical
data in a well-established prospective population-based cohort. ii) The use of longitudinal data to evaluate both
intra-individual and inter-individual variations in circulating protein levels over time on LOAD-related outcomes
provides unique prospects for robust biomarker findings. Finally, iii) the proposed study will use a novel and
recently developed protein detection technique to identify protein isoforms that may be linked to incident LOAD.
In conclusion, the proposed study findings will set the framework for the development of robust protein
biomarkers that represent different stages of the LOAD trajectory, allowing for early detection and intervention
management when effective primary prevention treatments become available.

Public health relevance
Narrative: The incidence of late-onset Alzheimer’s disease is on the rise with increasing aging of the population, yet there is a critical gap in understanding the biological processes that initiate and drive the disease from a preclinical to a symptomatic stage. The proposed project aims to identify molecular patterns that contribute to, or are affected by, the different phases of the Alzheimer’s disease trajectory from preclinical stage to clinical diagnosis. This will be achieved through the integration of both cross-sectional and longitudinal measurements of over 10,500 proteins in serum via advanced proteomic technologies, combined with high-sensitivity phosphorylated Tau-217 measurements, genetic and clinical data from two generations of the AGES-Reykjavik and the OFFGEN (AGES-Reykjavik offspring) cohorts, offering opportunities to identify novel biomarkers and therapeutic target candidates.